MOLECULAR BASIS OF RENAL CYSTIC DISEASE

Support is requested for organizing the conference, "Molecular Basis of Renal Cystic Disease," which will be convened May 13-15, 1994 in Ontario, Canada. It is one of the several Foreffronts in Nephrology series sponsored by the International Society of Nephrology. It will represent a gathering of biochemists, cell biologists, molecular biologists, developmental biologists, physiologists, and clinical investigators (both pediatric and adult nephrologists) who are actively engaged in studies of renal cystic disease at the basic level. In efforts to recruit, nurture, train and develop additional future researchers in the renal cystic disease area of nephrology, it is proposed by the organizers that a travel grant program, which offers a limited number of travel awards, be made available to ensure that young investigators are able to participate in this conference. These awards will be limited to young investigators and advanced fellows and trainees. Special consideration will be given to female and under-represented minorities. The co-chairmen of the conference will serve as the screening and selection committee, and the applicant organization will act as the fiscal agent and award the travel grants. The request of $10,000 from the National Institutes of Health will be used explicitly for travel awards to be given to awardees from North America.